Nocturnal hypoxemia dysregulates skeletal muscle protein homeostasis in COPD

Chronic obstructive pulmonary disease (COPD) is the 4th most common cause of death in the United States.
Sarcopenia, or skeletal muscle loss, impacts up to 40% of COPD patients and is a major cause of morbidity
and mortality. Despite the high significance, there are currently no effective therapies for sarcopenia in COPD
due to limited understanding of the underlying mechanisms of skeletal muscle loss. However, we have
identified that nocturnal hypoxemia, or low oxygen saturation during sleep and normal oxygen saturation while
awake, is associated with sarcopenia in COPD patients. Nocturnal hypoxemia causes tissue-level hypoxia in
the skeletal muscle, a condition we have termed prolonged intermittent hypoxia (PIH). Our preliminary and
published data indicate that PIH upregulates hypoxia inducible factor (HIF)1α-dependent gene targets whose
products dysregulate important muscle signaling and metabolic pathways to cause sarcopenia. These findings
support the hypothesis that PIH induces HIF1α activity in skeletal muscle leading to sarcopenia in COPD. This
hypothesis will be tested in vitro and in vivo in two specific AIMS. In Aim 1, we will determine the role of HIF1α
on key aspects of skeletal muscle protein synthesis and homeostasis in response to PIH in vitro using
loss/gain of HIF1α in murine myotubes and primary muscle cultures from murine and human models. In Aim 2,
we will determine the role of HIF1α on key aspects of skeletal muscle protein synthesis, homeostasis and
muscle function in response to PIH in live mice ± experimentally induced COPD ± PIH ± muscle specific
deletion of HIF1α. Our proposal is innovative in concept because our novel model of PIH is a clinically relevant
model that COPD patients routinely experience and is associated with sarcopenia. Our studies have the
potential for broad application and high clinical relevance because PIH occurs in other pulmonary disorders
associated with sarcopenia, such as interstitial lung disease or pulmonary hypertension. The proposed
research is significant because this work may identify novel therapeutic targets in the treatment of sarcopenia
in patients with COPD. This research will be performed in the laboratory of Dr. Dasarathy, Lerner Research
Institute (LRI), Cleveland Clinic, and will be advised by experts in the field of muscle biology, lung biology,
hypoxia, and COPD. Along with my mentor, my advisory panel has created a structured career development
program, including formal coursework in molecular biology and translational research. My career goal is to
build and lead an independent research program that will advance scientific knowledge and patient care in the
field of COPD, hypoxia, and sarcopenia. Commitment to research, exceptional mentorship, and strong
institutional support will allow me to become an independent and productive physician scientist.

Public health relevance
Sarcopenia, or skeletal muscle loss, is common in patients with chronic obstructive pulmonary disease (COPD); however the underlying molecular mechanisms are poorly understood. Our proposal will identify how prolonged intermittent hypoxia (PIH), a common condition in COPD, dysregulates HIF1α-mediated responses to cause sarcopenia. Determining the mechanisms by which HIF1α mediates skeletal muscle loss has the potential for broad application and high clinical relevance, which may result in novel and effective therapies to abrogate skeletal muscle loss in COPD.